MEASUREMENT OF CHROMOPHORES IN MAJOR DEPRESSIVE DISORDER

We have submitted samples for glycagon analysis in 37 subjects to compare levels in normal volunteers and winter depressives. We are continuing to enroll subjects and compile data.